Fecal microbial transplantation for chemotherapy behavioral side effects

PROJECT SUMMARY/ABSTRACT
Mental side effects of chemotherapy reduce quality of life and treatment dosing, thereby increasing mortality.
Current supportive care treatments are ineffective, thus identifying new interventions to prevent or reduce these
adverse side effects are crucial. We and others have recently hypothesized that gut dysbiosis may contribute to
the behavioral side effects of chemotherapy. Our long-term goal is develop novel microbial-based treatments for
the devastating side effects of the large and growing populations of chemotherapy-treated patients. The gut
microbial community is dramatically altered by chemotherapy and has recently been shown to communicate with
the brain to affect behavior. Indeed, we have previously published that altered composition of the gut microbiota
due to chemotherapy in mice drives central and systemic inflammation resulting in selective behavioral side
effects. Thus, the overall objective here is to determine the potential and feasibility of using fecal microbial trans-
plant (FMT) as an intervention for chemotherapy behavioral side effects. Three specific aims are proposed to
study this objective using our murine chemotherapy model (Aims 1 & 2) and a feasibility pilot clinical trial in breast
cancer patients receiving chemotherapy (Aim 3). Aim 1 will quantify the efficacy of healthy FMTs in ameliorating
sickness and cognitive behaviors during chemotherapy. Efficacy of autoFMT, alloFMT, or saline delivered in a
preventative or therapeutic paradigm on sickness and cognitive behaviors will be assessed during chemotherapy
treatment in mice after mammary tumor resection. Aim 2 will identify the systemic and neurobiological correlates
of FMT interventions during chemotherapy. The efficacy of the FMT treatments on systemic and central inflam-
matory signals, and the specific role of microglia, will be assessed during chemotherapy in mice after tumor
resection. Aim 3 will pilot the feasibility of investigating the therapeutic potential for FMT to alleviate behavioral
and gastrointestinal chemotherapy side effects in early-stage breast cancer patients. A small group of patients
receiving chemotherapy will undergo an autoFMT or standard of care. Side effects will be assessed before and
after FMT. The proposed research is conceptually innovative and our interdisciplinary team will be the first to
use novel therapeutic FMT for chemotherapy-induced behavioral side effects in a combined basic and clinical
approach. This research project will provide the necessary mechanistic and clinical foundation for future pro-
posals focused on larger clinical FMT trials. This is the first step along a microbial research arc that has the
potential to alter how common chemotherapy drugs are administered.

Public health relevance
PROJECT NARRATIVE The proposed translational research is relevant to public health because it will launch our understanding of if and how fecal microbial transplant treatment strategies may ameliorate the negative consequences of chemotherapy. Thus, the proposed research is relevant to part of NCI/NIH’s mission that pertains to reducing cancer-related comorbidities, which in turn, improves health and quality of life.